Image-guided TRAIL-enhanced CAR T-cell immunotherapy

PROJECT SUMMARY
Cancer cells have been shown to be sensitive to apoptotic stimulus of tumor necrosis factor α-related
apoptosis-inducing ligand (TRAIL), whereas normal cells showed very little response. TRAIL was shown to be
active as a single agent and exhibited synergistic activity with certain chemotherapeutic agents or
radiotherapy, causing marked regression or complete remission of tumors. There is increasing evidence that
membrane-bound TRAIL expressed on the surface of activated T-lymphocytes can enhance T-cell effector
function and augment T-cell tumoricidal activity. The ability to genetically engineer primary T-cells creates new
and highly promising prospects for tumor immunity and cancer treatment. The transduction of T-cells with
genes encoding chimeric antigen receptors enables T-cell recognition of antigens that are either poorly
immunogenic or ignored by the immune system. In addition, the genetically engineered expression of
therapeutic ligands (e.g. TRAIL) by T-cells can potently increase their tumoricidal activity. New strategies for
tumor sensitization to TRAIL-based immunotherapies and modulation of TRAIL resistance are being developed
and some can be translated to the clinic. Our central theme and hypothesis is that TRAIL overexpression by T-
cells results in augmented apoptosis in tumor cells and that radiation and/or chemotherapy positively affect
TRAIL-mediated tumor apoptosis during T-cell adoptive immunotherapy and can be used as a synergistic
approach to enhance T-cell tumor targeting and effector function.
In this application we propose to develop and test a novel theranostic approach to augment tumor apoptosis in
a prostate cancer model with heterogeneous PSMA levels using TRAIL overexpression by chimeric antigen
receptor (CAR)-grafted PSMA-specific T-cells. We will assess the effect of membrane-bound vs. secretable
forms of TRAIL expressed by PSMA-specific T-cells on their ability to kill PSMA-positive and -negative targets.
We will determine whether radiation/chemotherapy-induced “sensitization” of TRAIL-resistant tumor cells
correlates with an improved T-cell tumoricidal function. Ultimately, we will assess the feasibility and sensitivity
of PET imaging to monitor PSMA-specific T-cell activation and delivery of TRAIL therapeutic payloads to the
tumor. These processes will be monitored using multi-reporter gene and conventional imaging by assessing T-
cell tumor targeting and activation as well as tumor response.
Our proposal complements on-going clinical studies at MSK and other cancer centers by exploring new
strategies designed to enhance T-cell effector function and improve treatment response. The results will
provide preclinical support and justification to move toward clinical application in patients with prostate and
other cancers undergoing immunotherapy with genetically modified T-cells.
!

Public health relevance
PROJECT NARRATIVE The ability to genetically engineer primary T-cells creates new and highly promising prospects for tumor immunity and cancer treatment, specifically, the transduction of T-cells with genes encoding chimeric antigen receptors and therapeutic payload enables T-cell recognition of antigens that are either poorly immunogenic or ignored by the immune system, with successful tumor eradication. Our central theme and hypothesis is that tumor necrosis factor α-related apoptosis-inducing ligand (TRAIL) overexpression by T-cells results in augmented apoptosis in tumor cells and that radiation and/or chemotherapy positively affects TRAIL-mediated tumor apoptosis during T-cell adoptive immunotherapy and can be used as a synergistic approach to enhance T-cell tumor targeting and effector function. Here, we propose, under image guidance, to develop new strategies for prostate cancer sensitization to adoptive anti-PSMA T-cell-based immunotherapies for subsequent translation to the clinic.